Membrane Ubiquitin Ligase-Driven Immune Evasion in HPV+ Head and Neck Cancer

PROJECT SUMMARY
Human papillomavirus (HPV) is the causative agent of 5% of all human cancers, including 25% of head and neck
squamous cell carcinomas (HNSCCs). HPV-driven disease progression requires both persistent infection and
evasion of the host immune response. One mechanism of immune evasion employed by many cancers, including
HPV+ HNSCCs, is the downregulation of major histocompatibility complex class I (MHC-I) on the surface of
tumor cells. MHC-I antigen presentation is crucial for recognition of tumor cells by CD8+ T cells during the
antitumor response and is a major contributor to lack of patient response to immune checkpoint inhibitor therapy.
Our lab has previously shown that an E3 ubiquitin ligase upregulated in HPV+ HNSCCs, MARCHF8,
ubiquitinates immune surface receptors, including MHC-I, for subsequent degradation. Further, a genome wide
CRISPR screen identified genes involved in autophagy, a cellular degradation pathway, as candidates for
negative regulators of MHC-I. Based on these findings, I hypothesize that MARCHF8 upregulation by
papillomaviruses promotes immune evasion by directing MHC-I for autophagic degradation. To test this
hypothesis, I will 1) investigate the mechanism of MARCHF8-mediated MHC-I ubiquitination and degradation via
the autophagy pathway and 2) evaluate inhibition of autophagy as a novel treatment for HPV+ HNSCC. With
these aims, this project will uncover a mechanism of immune evasion during papillomavirus-induced
carcinogenesis.

Public health relevance
Narrative: This study will contribute to the mechanistic understanding of how HPV upregulation of MARCHF8 remodels the tissue/tumor microenvironment to promote HNSCC. Further, uncovering mechanisms of HPV immune evasion may help identify novel targets for immunotherapies that enhance current treatments for HPV+ HNSCC patients.